Probing Intra-voxel Tissue Heterogeneity Using MRI

ABSTRACT
Biological tissues are heterogeneous, particularly at a microscopic scale (e.g., ~10"mu"m). The degree
of tissue heterogeneity plays a very important role in tissue characterization, disease diagnosis, and
monitoring treatment efficacy. In cancer, for example, intra-tumor heterogeneity has been identified as one
of the most important factors in cancer staging and individualized treatment, as demonstrated in a number
of recent papers in high-impact journals. Tissue heterogeneity arises from a variety of origins, such as
genetics, epigenetics, physiology, and pathology, all of which lead to structural heterogeneity at a specific
spatial scale. Studying tissue structural heterogeneity, therefore, can provide a unique avenue to probe the
underlying biological processes. Current spatial resolution for human MRI, unfortunately, is far from
adequate to visualize tissue structural heterogeneity at a microscopic level (e.g., ~5-50 "mu"m). Efforts to
further improve the resolution face formidable technical challenges. An alternative strategy is to use the
present spatial resolution, but focus on extracting sub-voxel information by linking a macroscopic voxel-level
measurement to a microscopic intra-voxel physical process that reflects tissue structural heterogeneity.
Using a novel diffusion model based on fractional order calculus (FROC), our group, echoed by others, has
observed an increasing number of evidences suggesting a link between a macroscopic diffusion parameter
and microscopic intra-voxel tissue heterogeneity. The overarching goal of the proposed project is to further
develop and validate this promising diffusion imaging technique, and demonstrate that a set of FROC
parameters can enable characterization of intra-voxel tissue heterogeneity in human subjects.
The scientific premise of the project is that microstructural heterogeneity is an important tissue
feature and that advanced diffusion MRI based on the FROC model can non-invasively assess
microstructural heterogeneity, leading to new imaging markers. Our central hypothesis is that diffusion
behavior in tissues at high b-values can be characterized by a heterogeneous diffusion process, and the
degree of diffusion heterogeneity can be directly linked to intra-voxel tissue structural heterogeneity. The
project has four Specific Aims. First, we will optimize a high-resolution diffusion imaging technique to
enable accurate measurement of intra-voxel diffusion heterogeneity. Second, we will generalize the FROC
diffusion model to account for intra-voxel diffusion heterogeneity not only spatially but also temporally. Third,
using the techniques in the first two aims, we will demonstrate the possible relationship between MRI-based
intra-voxel diffusion heterogeneity and histology-based structural heterogeneity on postmortem human
brains with glioma. Finally, we will extend the demonstration to in vivo studies on sixty brain tumor patients
using stereotactic biopsies. Taking together, the project will address a significant unmet need that is of great
importance in biological sciences and clinical medicine, especially cancer.

Public health relevance
Project Narrative Tissue heterogeneity at the microscopic level contains valuable information of the underlying biological processes that are of great importance for monitoring disease progression and regression, understanding disease mechanisms, and ultimately developing effective therapies. The proposed project focuses on developing and validating a novel imaging tool for probing microscopic intra-voxel tissue heterogeneity on human subjects non-invasively and non-destructively. Successful completion of the project will address a significant unmet need in biological sciences and clinical medicine, and provide new insights into diagnosis and treatment of a host of diseases, especially cancer, that involve alterations in tissue microstructural heterogeneity.